SAVARY DILATION--INTRALESIONAL STEROIDS IN ESOPHAGEAL STRICTURE PATIENTS

To compare the long term efficacy of Savary dilation with and without Intralesional Steroids in Patients with Benign Peptic Esophageal Strictures